Disorder within Dialects: An Expanded Test of Tense and Agreement in Sentence Recall for Children with DLD

Project Summary
Tense and agreement (T/A) deficits are routinely assessed and treated when children with
Developmental Language Disorder (DLD) speak mainstream dialects of English and other languages, yet these
grammar structures are typically excluded from clinical practice when children with DLD speak a nonmainstream
dialect of English, such as African American English (AAE) or Southern White English (SWE). Excluding such
structures is grounded in a fear of misinterpreting a child's nonmainstream dialect forms as a disorder, yet this
practice leads to a disparity in the structures that can be assessed and treated across dialects. Fortunately, in a
recent NIH-funded study conducted in the Deep South, we created a novel dialect-informed and strategically
scored sentence recall task targeting T/A, and this task differentiated children with and without DLD within AAE
and SWE with relatively high levels of accuracy1. These results call for a paradigm shift and the inclusion of T/A
structures within clinical practice for all children.
The next step toward bringing a dialect-informed and strategically scored sentence recall task targeting
T/A to clinicians involves testing its ecological validity with children who present an expanded range of dialectal
and psycholinguistic profiles. In addition, there is a need to systematically test the T/A structures within the task
in different syntactic frames and evaluate the strategic scoring approach to further understand and maximize
their contribution to diagnostic outcomes. Finally, theoretical questions exist as to why sentence recall might be
a good discriminator of children with and without DLD across dialects, with one possibility being that this task
interfaces with additional abilities that differentiate these groups beyond children's T/A systems, such as their
vocabulary, working memory, and phonological short-term memory2,3. If so, we need to know if sentence recall
interfaces with these abilities differentially depending on a child's clinical status and/or dialectal profile.
Working within an innovative Disorder within Dialects framework, the proposed project seeks to further
test the diagnostic accuracy and theoretical basis of a sentence recall task targeting T/A by: recruiting children
who produce an expanded range of AAE and SWE (Aim 1); including children who present an expanded range
of nonverbal IQ scores (Aim 2); testing each T/A form in a variety of syntactic frames and evaluating the scoring
approach to optimize the task (Aim 3a and 3b); and testing between dialects and clinical groups, the relationship
between the children's sentence recalls, their T/A systems, and their other psycholinguistic abilities (Aim 4). To
achieve these aims, we will collect data from children with and without DLD in kindergarten and 1st grade in six
different dialect communities (AAE: rural, suburban, urban; SWE: rural, suburban, urban). The proposed work
will be the first of its kind to detail the dialectal and psycholinguistic variation that exists between and within AAE-
and SWE-speaking children who live in the Deep South and evaluate with rigor a sentence recall task targeting
T/A for these children.

Public health relevance
Project Narrative Health disparities exist for children who live in the Deep South, and these include inequities in our understanding of Developmental Language Disorder (DLD) in children who speak various nonmainstream dialects of English and in the materials and methods used to identify and treat children within DLD within these dialects. Using an innovative Disorder within Dialects framework, the proposed studies seek to further test a sentence recall task targeting tense and agreement (T/A) for its diagnostic accuracy and theoretical basis by expanding the type of child profile studied, examining the T/A structures in various syntactic frames, testing the nature of the scoring, and conducting several across-dialect and dialect-specific analyses of the data. The findings will advance our understanding of DLD within various dialects of English and move us one step closer toward developing dialect-appropriate and diagnostically accurate assessments, which should help reduce health disparities in children who live in the Deep South and elsewhere.